An Evaluation of the Impact of Restaurant Sanitary Grade Posting on Health Hazard

DESCRIPTION (provided by applicant): Project Summary/Abstract To reduce risks of food borne illness resulting from poor sanitary practices in restaurants, the New York City (NYC) Department of Health and Mental Hygiene is scheduled to require public posting of restaurant sanitary scores in the form of letter grades beginning July 2010. The rationale behind this effort is that increased public access to restaurant scores will compel restaurant operators to better comply with regulations designed to reduce risks of food borne illness. We propose to evaluate the extent to which grade-posting improves restaurant hygiene and reduces food borne illness in NYC. We also propose to use results from the evaluation to improve the effectiveness of practices within the NYC restaurant inspection program. To conduct this evaluation, we will use data from five sources: I. New York City restaurant inspection database (FACTS) - to monitor restaurant hygiene at baseline and over time. II. New York City Community Health Survey (CHS) - to track frequency of restaurant dining and awareness of inspection results among resident NYC adults. III. Restaurant Operator and Diner Surveys - two new surveys developed to measure restaurant industry and diner response to grade-posting. IV. New York State Statewide Planning and Research Cooperative System (SPARCS) inpatient hospital discharge and emergency department visit data - to track the occurrence of serious food borne illness in NYC. V. NYC Syndromic Surveillance System - to track the occurrence of diarrheal illness in NYC. We will conduct statistical analyses to describe and test for changes over time in metrics we have developed to represent a range of issues including restaurant compliance with critical food safety parameters, the occurrence of food borne illness in NYC, the impact of grade cards on public awareness of restaurant hygiene, the impact of grade cards on influencing restaurant choice, and the NYC restaurant industry's response to grade-posting. We will incorporate information from this evaluation into restaurant inspector and restaurant operator training programs and online resources.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative To reduce risks of food borne illness resulting from poor sanitary practices in restaurants, the New York City (NYC) Department of Health and Mental Hygiene is scheduled to require public posting of restaurant sanitary scores in the form of letter grades beginning July 2010. The rationale behind this effort is that increased public access to restaurant scores will compel restaurant operators to better comply with regulations designed to reduce risk of food borne illness. We propose to evaluate the extent to which grade-posting improves restaurant hygiene and reduces the occurrence of foodborne illness in NYC. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The New York City (NYC) Department of Health & Mental Hygiene (DOHMH) is scheduled to require public posting of restaurant sanitary scores in the form of letter grades beginning July 2010. The rationale behind this effort is that increased public access to restaurant scores will compel restaurant operators to better comply with food service regulations designed to reduce risk of foodborne illness. Our overarching goal is to reduce the risk of foodborne illness attributable to restaurants by improving compliance with safe sanitary practices. We expect the proposed research to provide evidence-based support for grade-posting as a means towards this goal. Specific Aim 1: Measure how much restaurant grade-posting increases public awareness of inspection results and influences choice of restaurant. Aim 1.1: Compare public awareness of restaurant inspection results before and after grade-posting, using the annual NYC Community Health Survey (CHS) 2009 and 2012. Aim 1.2: Describe the likelihood that a NYC resident will select a restaurant based on a posted grade, along with reasons why or why not, using the CHS 2012, supplemented with a diner telephone survey. Specific Aim 2: Measure how much the letter grading initiative reduces the presence of serious health hazards in restaurants. Aim 2.1: Describe the yearly change in average inspection score per restaurant, with scoring limited to critical violation categories (improper cooking, holding temperatures, handwashing, contaminated food contact surfaces, food source), Aim 2.2: Describe the yearly change in the proportion of restaurants operating with a score that is associated with a grade lower than "A". Aim 2.3: Describe the yearly change in the numbers of critical violations within specified categories (improper cooking, holding temperatures, handwashing, contaminated food contact surfaces, food source). Aim 2.4: Describe the yearly change in the proportion of restaurants closed at routine inspection. Specific Aim 3: Determine if foodborne illness decreases as a result of the grade-posting initiative. Aim 3.1: Describe the rates of hospitalizations and emergency department visits for foodborne illness during the course of restaurant grading implementation. Aim 3.2: Compare the period prevalence of diarrheal episodes reported on the CHS prior to the restaurant grading initiative (CHS 2003) and after implementation (CHS 2013). Aim 3.3: Track diarrheal episodes identified by Syndromic Surveillance (near real-time emergency department visits) before and after the implementation of grade-posting. Specific Aim 4: Develop strategies for gaining industry support of the grade-posting initiative. Aim 4.1: Measure industry response to the grading initiative by surveying restaurant operators about impact on sales and obstacles towards obtaining an "A" grade. Aim 4.2: Measure impediments towards achieving an "A" grade by analyzing frequencies of persistent violations. Aim 4.3: Measure industry impact by comparing survey data on frequency of dining out before and after the start of grade-posting, collected using the CHS 2005, 2009 and 2012. Aim 4.4: Measure industry impact by tracking the percentage of restaurants closed, days in closure, and restaurant "survival" time over sequential time frames. Specific Aim 5: Enhance the ability of over 150 public health sanitarians (PHS) to conduct assessments of critical restaurant hygiene violations, and to educate restaurant operators in safe sanitary practices. Aim 5.1: Use data collected by the evaluation project to conduct workshops for PHSs on the role of the inspection process in preventing foodborne illness.